Mechanisms Underpinning Afterload-Induced Atrial Fibrillation

PROJECT SUMMARY
Atrial Fibrillation (AF) is the most common sustained arrhythmia among adults. In AF, dysfunctional atrial
cardiomyocytes (aCMs) and fibrosis within the atrial wall result in abnormal impulse generation and disorganized
wave front propagation, preventing a coordinated atrial contraction, ultimately increasing the risk of
thromboembolic stroke and heart failure in patients. Hypertension predisposes patients to AF due to the
increased afterload, or pressure the heart must work against. In addition, the NLRP3 inflammasome has been
shown to be consistently activated in AF patients, however, the mechanism of activation has yet to be explained.
Despite its growing prevalence, AF treatments remain inadequate. Clinically available anticoagulants and
antiarrhythmic drugs have dangerous side effects and fail to address the causal mechanisms of AF, including
the dysfunctional aCMs and fibrosis. Preventative strategies are limited to managing underlying conditions.
Given that AF is progressive in nature, preventing its onset in susceptible patients may yield better outcomes
and significantly improve patient survival. Therefore, we aim to investigate the mechanisms underlying electrical
and structural remodeling seen in afterload-induced AF to identify possible upstream targets. The overall
hypothesis is that elevated afterload in the cell-in-gel EHT platform will recapitulate pressure overload
seen in chronic hypertension and heart failure. The increase in afterload on our EHT will activate the
NLRP3 inflammasome, resulting in CF activation, pro-fibrotic signaling cascades, and
electrophysiological and structural remodeling seen in AF development. To achieve this, we will utilize a
novel physiologically relevant model of AF. Engineered heart tissue, composed of decellularized human atrial
tissue recellularized with hiPSC derived aCMs and cardiac fibroblasts, will recapitulate the heterogeneity,
complex structure, and functionality of native atrial myocardium. This tissue will be encased within a stiff polyvinyl
alcohol hydrogel that will apply multiaxial stress to it. This will mimic the increased afterload seen in hypertension.
This novel platform will provide the field with a new and relevant in vitro model of human AF. We will observe
AF-like remodeling in loaded control engineered tissue along with an NLRP3-/- tissue. These experiments will
determine the critical roles of afterload and the NLRP3 inflammasome in AF development. This research could
elucidate the steady rise in AF occurrence and actively work to curtail its prevalence.

Public health relevance
PROJECT NARRATIVE Atrial Fibrillation (AF) is the most common arrhythmia affecting 46 million people globally. More relevant in vitro models of the condition are needed to identify novel preventative therapeutic targets to curtail the steady increase in prevalence. Our human induced pluripotent stem cell derived atrial cardiomyocytes, cardiac fibroblasts, and decellularized extracellular matrix based engineered heart tissue incorporated into our collaborator’s Cell-in-Gel platform has promising potential to accurately recapitulate AF development and allow us to elucidate the mechanisms underpinnings afterload-induced AF.